Characterizing Tissue Specific Regulation of Mutant Lamin Protein Degradation

Project Summary Laminopathies are a wide range of disorders that include both multisystem disorders such as the aging disorder Hutchinson Guilford Progeria and tissue specific disorders such as Emery-Dreifuss Muscular Dystrophy and the neuropathy Charcot-Marie-Tooth disease. All of these different disorders can be caused by mutations in the LMNA gene, however, how mutations in one gene give rise to such different disorders is incompletely understood. Mutant forms of lamin protein have been found to aggregate, and this aggregation is associated with impaired cellular function and disease phenotypes. Therefore, we hypothesize that certain tissues are susceptible to specific lamin mutations due to the inability of tissue specific quality control mechanisms to degrade those mutant forms, leading to protein aggregation and cellular toxicity. We will test this hypothesis using the fruit fly Drosophila melanogaster as our model system. Drosophila allow us to manipulate gene expression in specific tissues, enabling experiments to tease apart how different lamin protein mutations are degraded in specific tissues. Flies have two homologues of the human LMNA gene, LamC and Lam Dm0, and mutations in these genes mimic human disorders. In addition, introducing the equivalent mutations that cause human disease into LamC results in lamin protein aggregation and disease-like phenotypes. Furthermore, AMPK signaling, which is downregulated in muscle biopsies from patients, has been found to reduce mutant LamC aggregation in the fly muscle. On the other hand, we find that Lam Dm0 aggregates in the muscle during aging, and that p38 MAPK (p38Kb) and the CASA complex regulate the degradation of Lam Dm0. One difference between LamC and Lam Dm0 is that while with both lamins are expressed in muscle, only Lam Dm0 is expressed in neurons. As LamC and Lam Dm0 have different tissues specificities, we can also assess if specific protein quality control mechanisms are able to target certain mutant forms of lamin in each tissue. This will allow us to determine if disease tissue specificity is due to the failure of protein quality control machinery to degrade certain mutant forms of lamin protein, resulting in muscular dystrophy rather than neuropathy, for example. Therefore, we will 1) determine if p38Kb and the CASA complex regulate the aggregation of specific forms of mutant LamC proteins and how this contributes to muscle defects, 2) characterize how specific disease mutations in Lam Dm0 affect aggregation in muscles and neurons, and 3) determine if AMPK and p38Kb act in the same or different pathways to regulate mutant lamin aggregation. We expect that our proposed study will provide new insights into how mutant forms of lamin result in a disease state and if activating different protein quality control mechanisms could prove to be an effective therapeutic mechanism.

Public health relevance
Project Narrative Laminopathies are a wide range of disorders caused by mutations in the lamin genes. How different mutations in the lamin genes can give rise to distinct diseases that affect specific tissues is not well understood. Therefore, we propose to use the fruit fly Drosophila melanogaster to determine if this disease specificity is due to the differential ability of tissues to degrade mutant lamin proteins.